The Total Synthesis and Biological Evaluation of Drimane Sesquiterpenoids

Project Summary:
Antimicrobial resistance (AMR) is a grave public health concern resulting in millions of infections in the
United States each year. These resistant infections place a high financial burden on patients and the healthcare
system. At the center of these resistant infections are six opportunistic “ESKAPE” pathogens (Enterococcus
faecium, Staphylococcus aureus, Klebsiella pneumoniae, Acinetobacter baumannii, Pseudomonas aeruginosa,
and Enterobacter spp.), which cause over half of all healthcare-associated infections. As such, there is a dire
societal need to develop novel antimicrobial compounds with unique mechanisms of action (MOA) to combat
these ubiquitous pathogens. Targeting a novel MOA decreases the likelihood of cross-resistance. To identify
new compounds with potent biological activity and potentially a new MOA, we turn to natural products. Natural
products are secondary metabolites that have been used for their medicinal properties thousands of years.
Today, upwards of one-third of all FDA-approved drugs come from natural products. Taken together, natural
product synthesis represents a valuable starting point for the discovery of antimicrobial compounds with a novel
mechanism of action.
The drimane sesquiterpenoid family of natural products has potent activity against a wide range of
antimicrobial pathogens including Pseudomonas aeruginosa and Staphylococcus aureus. Drimane
sesquiterpenoids are structurally distinct from traditional antibiotics, suggesting they may have a novel MOA.
However, their scarce supply in nature limits our understanding of their biological activity. This application
proposes the total synthesis of over 15 drimane sesquiterpenoids from a single precursor, all with underexplored
or unreported biological activity. Additionally, we will use this diverted synthetic platform to conduct a hypothesis-
driven analog campaign to yield unnatural analogs with superior biological properties. With this library of
synthetic compounds, we will perform a series of biological assays including resistance selection to elucidate
the mechanism of action of these drimane sesquiterpenoids. This interdisciplinary proposal will propel our
understanding of these potent antimicrobial natural products and potentially identify a novel target for further
antibiotic drug development.

Public health relevance
Project Narrative Antimicrobial resistance is a serious public health concern resulting in increased hospitalization, healthcare costs, and deaths. Consequently, there is a need to develop and study new antimicrobial compounds with unknown mechanisms of actions, such as the drimane sesquiterpenoids family of natural products. We plan to synthesize multiple drimane sesquiterpenoids natural products along with strategically designed analogs to further examine their antimicrobial ability and shed light onto their potential mechanism of action.